Project 2: Targeting MYC in Colorectal Cancer

PROJECT SUMMARY/ABSTRACT: Project 2
MYC oncoprotein transcription factors are overexpressed in a majority of malignancies and contribute to
~100,000 cancer-related deaths each year in the USA. There is a clear unmet need for targeted therapies to
treat MYC-driven cancers, especially in colorectal cancer (CRC), where dysregulation of Wnt/β-catenin
signaling leads to pathophysiological activation of the canonical c-MYC protein. MYC itself, however, is widely
viewed as undruggable, meaning that innovative new strategies are needed to pharmacologically thwart MYC
function in CRC. Together with the Fesik laboratory, we pioneered and reduced to practice the idea that MYC
can be targeted through WDR5, a co-factor that it uses to drive enhanced protein synthesis in cancer cells.
Supported by the NCI Experimental Therapeutics (NExT) Program, we developed a potent and orally
bioavailable inhibitor of the "WIN" site of WDR5, characterized its mechanism of action, and showed that it is
active against hematologic malignancies in vivo. A clinical candidate WIN site inhibitor (WINi) was recently
declared and is making its way to IND enabling and a phase I clinical trial. Supported by this GI SPORE, we
have laid the foundation for the application of WINi for the treatment of CRC. In the last cycle, we exposed
the mechanism of action of WINi in CRC, showed single agent activity against CRC in vivo, and identified
genetic modifiers of response as well as potential drug combinations that can increase WIN site inhibitor
activity. In this renewal, we will gather essential new information to support the clinical implementation of WINi
for the treatment of CRC. Cutting edge genetic, genomic, and proteomic approaches, together with
sophisticated tissue culture models, will be deployed to identify and validate patient selection criteria, predict
pathways of resistance, identify and validate surrogate biomarkers, and prioritize mechanism-driven drug
synergies. The resulting biological insight and output will be used to support a phase II clinical trial to
determine the efficacy of WIN site inhibition in CRC patients. Backed by the superb resources and
infrastructure of the Vanderbilt GI SPORE, an experienced and capable team, and a highly-vetted clinical
candidate WINi, this project is poised to complete the first-in-class trial of a new therapy for patients with
metastatic CRC for which there are currently very limited treatment options. Results of these studies will also
lay the foundation for the clinical application of these agents against other solid tumor types.

Public health relevance
PROJECT NARRATIVE: Project 2 MYC proteins feature prominently in the initiation and progression of many malignancies, including colorectal cancer, and are a promising target for the discovery of novel anti-cancer therapies. In this project, we will pursue a promising strategy to target MYC in colorectal cancer via its partner protein WDR5. Completion of the proposed studies will lay the foundation for the clinical application of inhibitors of the MYC–WDR5 connection for the treatment of colorectal cancer and other cancer types.